Intracellular organelle deficits driving Alzheimer's disease

Alzheimer’s disease (AD) is a devastating neurodegenerative disorder characterized by aggregation of β-amyloid
(Aβ) peptides, neurofibrillary tangles composed of hyperphosphorylated tau, and a progressive loss of cognitive
function. While much is known regarding the biochemical composition and structure of amyloid and tau in AD,
relatively less focus has been placed on the intracellular handling of detrimental protein products, and more
specifically, how upstream deficits in organelle function can accelerate the disease process and directly
contribute to memory impairments. While neurons rely on dedicated organelles to execute specific functions and
sustain health, several in particular have been linked to AD pathophysiology, including the ER, which is important
for protein assembly and intracellular calcium signaling; lysosomes, which are critical for breaking down and
removing the cellular debris and misfolded proteins collected by authophagosomes; and mitochondria, which are
responsible for the bioenergetics of the cell (Mustaly et al., 2018). In the global operations of maintaining
neuronal viability, the functions of these organelles are highly inter-dependent, and they are often physically
coupled to one another. Despite the close coupling, their respective roles in contributing to AD have typically
been studied in isolation. For example, there are compelling studies detailing aspects of ER, lysosome, or
mitochondrial dysfunction in AD, yet substantially less is understood about how altered interactions among these
organelles can lead to pathogenic cascades. This isolationist approach may lead to critical oversights in
understanding key processes in AD and missing potential therapeutic opportunities. Thus, the overall goal of
this study is to identify mechanisms underlying deficiencies in specific organelle functions and examine how this
affects their interactions, characterize how this potentiates AD pathology, and establish the upstream drivers of
this cascade for consideration as a therapeutic target. This will be accomplished through the following Aims: Aim
I: Determine if the AD-associated disruption in ER function disrupts lysosomal dynamics and clearance of
aggregated proteins. Aim II: Determine the mechanism by which excess ER-Ca2+ release disrupts mitochondrial
function and degradation. Aim III: Establish upstream drivers of intracellular pathogenic cascades and determine
if targeting ER-homeostasis will resolve lysosomal and mitochondrial defects. The proposed study will have a
significant impact on the field as it will provide new mechanistic information about how misaggregated proteins
accumulate in AD and are associated with altered ER signaling. Moreover, targeting specific intracellular
organelles may reveal effective new treatment strategies for AD.

Public health relevance
The objective of this study is to determine the pathogenic signaling interactions among key neuronal organelles that contribute to AD pathology. Specifically, we will examine functions of the ER, lysosomes, authophagosomes and mitochondria in AD mouse models and human neurons from AD patients to discover how dysfunction in one organelle disrupts the functions of others, leading to pathogenic protein aggregates and synaptic defects. Benefits to public health include the identification of new cellular pathogenic dynamics and development of novel therapeutic strategies to effictively treat AD.